Genetics and Genomics Core

PROJECT SUMMARY – GENETICS AND GENOMICS CORE
The Genetics and Genomics Core provides advice, services and hands-on-training to Diabetes
Research Training Center (DRTC) investigators on the design and implementation of genetics and
genomics studies in diabetes-related research. The Core serves not only DRTC-affiliated investigators
but also diabetes investigators carrying out diabetes-related research throughout the United States and
internationally. The same technology making genomic variation information accessible to everyone
requires increasingly sophisticated analytic strategies not in the repertoire of most investigators. The
core focuses on the analysis and interpretation of genetic studies of diabetes, identification of diabetes-
associated variants and predicted functionality of those variants. The Core maintains the Monogenic
Diabetes Registry that provides clinical and genetic data on more than 700 individuals with a genetic
form of diabetes representing a living biobank for cell biological and physiological studies. The growing
awareness of the role of genetics as a primary cause of diabetes among patients and physicians has
led the Core to become a national resource for genetic testing and interpretation of genetic testing
results. In this regard, the Core has developed next generation sequencing based panels for screening
for mutations in diabetes and obesity genes. It has also developed novel methods (PrediXcan and
MetaXcan) for integrating genetic and gene expression data. The Genetics and Genomics Core
integrates with the other Biomedical Research Cores by providing samples and data from patients with
specific genetic forms of diabetes to the Cell Biology, Circadian Rhythms and Physiology Cores.